Dissecting the role of B lineage cells in mediating response of resectable lung cancer to neoadjuvant immune-based therapy

PROJECT SUMMARY
Neoadjuvant and perioperative chemoimmunotherapy are the standard of care for the treatment of patients with
resectable non-small cell lung cancer (NSCLC). Unfortunately, the majority of patients with resectable NSCLC
do not benefit from neoadjuvant/perioperative immune checkpoint inhibitor (ICI)-based therapies for reasons
that are unclear. Efforts to develop more effective treatment strategies that bypass therapeutic resistance have
been hampered by our limited understanding of the mechanisms that govern response to ICIs and that thus
could serve as validated biomarkers to guide neoadjuvant/perioperative ICI treatment. Our long-term objectives
are to develop rational neoadjuvant/perioperative combination therapies that prevent resistance and increase
benefit from ICI-based treatments. Recently, we analyzed NSCLCs from patients treated with chemotherapy
(CT) plus dual ICIs in the phase 2 NEOSTAR trial (PI: Cascone) and found those from responders contained
enhanced B cell fractions and markers of tertiary lymphoid structures (TLS) compared to nonresponders. These
findings were recapitulated when using neoadjuvant combinations of ICI plus novel immunomodulatory agents
in our recently reported phase 2 trial, NeoCOAST. To build on these observations from our clinical trials, we
performed preliminary spatial-omics analysis of a pilot cohort of NSCLCs from patients treated with neoadjuvant
CT+ICI and with varying response to therapy. We found that pathologic response was associated with
aggregation of B cells into organized structures (e.g., TLS) with elevated expression of anti-tumor B cell
signatures and enhanced cell-cell communication with the tumor immune microenvironment. Preclinically, we
found that neoadjuvant ICI-based therapy was the most effective treatment at reducing frequency of metastases
and prolonging survival in our human-relevant models of spontaneously metastatic NSCLC and therapeutic
efficacy was once again tightly coupled with enhanced B cell infiltration. Consequently, we hypothesize that B
cell transcriptional, immunogenomic, and spatial landscapes in neoadjuvant CT+ICI-treated NSCLC patients
differ by MPR, and that B cell-mediated cytotoxic antitumor responses, including their interaction with T cells,
augment the efficacy of neoadjuvant ICI-based therapy in early-stage NSCLC. We will test our hypothesis by
determining the transcriptional, immunogenomic, and spatial landscapes of B lineage cells in human NSCLC
treated with neoadjuvant ICI-based therapy (Aim 1); interrogating the impact of B cells on T cell-mediated
responses to neoadjuvant ICI-based therapy in murine models of NSCLC (Aim 2); and investigating the utility of
B cell-centric phenotypes in predicting benefit of neoadjuvant ICI-based therapy in resectable NSCLC from
unique clinical trials (Aim 3). This proposal will leverage a platform of unique, global clinical trial cohorts of
NSCLC, novel human-relevant mouse models of NSCLC, as well as state-of-the-art single-cell and spatial multi-
omics technologies to define the role of B cell lineages in antitumor responses to neoadjuvant ICIs and provide
a framework for the development of B cell-associated therapies aiming to cure a greater number of patients.

Public health relevance
PROJECT NARRATIVE While presurgical (neoadjuvant) and the combination of pre and postsurgical (perioperative) immune-based therapy, such as treatment with immune checkpoint inhibitors (ICIs), has markedly improved survival outcomes of patients with early-stage non-small cell lung cancer (NSCLC), there are still many patients who show inferior response and ultimately succumb to the disease. A better understanding of mechanisms that underlie resistance to neoadjuvant/perioperative ICIs is a crucial prerequisite for personalizing immunotherapy, predicting therapeutic response, and even developing new immune-based therapies that confer robust survival advantages for a greater number of patients with early-stage NSCLC. This project will use multiple, unique and richly annotated human cohorts, state-of-the-art clinical trials, experimental mouse models that closely recapitulate pre and perioperative immunotherapy, as well as single-cell sequencing and spatial transcriptomics technologies to understand how B lineage cells, that remain much understudied compared to other lymphocytes (T cells), mediate response of early-stage NSCLC to neoadjuvant and perioperative immune-based therapy.